Control of Cell Number in Developing Retina

Project Summary / Abstract
My long-term scientific goal is to understand the molecular mechanisms that specify retina cell number.
Using the compound eye of Drosophila as an experimental model, my laboratory has discovered the Hippo
pathway as a central mechanism underlying this process. The core of the Hippo pathway comprises a
kinase cascade in which the Ste20 kinase Hippo (Hpo) phosphorylates and activates the NDR family
kinase Warts (Wts). Wts, in turn, phosphorylates and inactivates the oncoprotein Yorkie (Yki) by excluding
it from the nucleus, where it normally functions as a coactivator for the DNA-binding transcription factor
Scalloped (Sd). Our research further established a critical role for the Hippo pathway in controlling organ
size in mammals, underscoring the importance of Drosophila as a powerful model to discover universal
developmental mechanisms.
Despite recent progress in elucidating the molecular underpinnings of the Hippo signaling pathway, our
understanding of this growth-regulatory pathway remains incomplete. In the current grant period, we have
further advanced our mechanistic understanding of the Hippo pathway, including a critical role for Spectrin in
coupling cortical tension, cell shape and Hippo signaling in retinal morphogenesis and the discovery of
biomolecular condensates as a unified mechanism by which upstream regulators of the Hippo pathway
integrate diverse physiological inputs into Hippo signaling. Our research also shed light on Hippo pathway
evolution by uncovering a critical role for Hippo signaling in a unicellular relative of metazoans. Meanwhile, we
continued to extend our Hippo pathway discoveries from Drosophila to mammalian biology. Highlights include
our elucidation of default repression as well as polyamine biosynthesis and DNA demethylation as key
transcriptional output of mammalian Hippo signaling and aberrant Hippo signaling as the pathological basis for
epithelioid hemangioendothelioma (EHE).
In the next grant period, we will further elucidate the molecular underpinnings of the Hippo pathway through the
following specific aims. First, we will investigate the function and regulation of Slmap condensates in mechano-
regulation of Hippo signaling. This aim will not only expand our understanding of Hippo pathway regulation by
mechanical forces, but also define endoplasmic reticulum as a novel subcellular hub for mechano-transduction.
Second, we will dissect the molecular and cellular mechanisms by which phosphatidylinositol-4-phosphate
(PI4P) on plasma membrane integrates upstream inputs of Hippo signaling to regulate Merlin function. This
aim will shed light on the control of plasma membrane PI4P level and distribution in developing tissues and
define how diverse signals converge on PI4P to regulate Merlin function. Lastly, we will characterize novel
regulators of the Hippo pathway identified from a sensitized genetic screen. This unbiased genetic approach
will shed light on previously unforeseen regulators/mechanisms underlying Hippo pathway regulation. Besides
revealing fundamental mechanisms of eye development, the proposed studies will have general implications
for the development of other tissues.

Public health relevance
Project Narrative The proposed studies will not only elucidate the fundamental mechanisms that regulate retina cell number, but also provide general insights into how cell number is determined in other organs during animal development and how aberrant regulation of this process could lead to tissue atrophy or hyperplasia. Such insights may facilitate the therapeutic interventions of relevant human diseases, including diseases of the retina.